Noncovalent interaction of mutant KRAS inhibitors

Abstract:
Oncogenic mutations in KRAS (mKRAS) are the main drivers for many human lung,
pancreatic, and colorectal cancers. For many years, these oncogenic mKRAS have been
considered undruggable, creating a significant unmet need. Recently, advancements in chemistry
have led to the development of novel covalent inhibitors of the KRAS G12C proteins that target
KRAS G12C-driven tumors. The encouraging outcomes of these G12C inhibitors have led to the
accelerated FDA approval of sotorasib and adagrasib for adult patients with NSCLC. Many other
mKRAS inhibitors targeting G12D and other mKRAS are also under development and evaluation
in various clinical trials. Many chemo-proteomic approaches have established the exquisite
specificity of various G12C inhibitors for Cys12 of the mKRAS proteins. However, the extent to
which these inhibitors target other non-KRAS proteins through non-covalent interactions is
unclear. To address this gap, we performed MS-based proteome-wide folding stability
measurements that showed that divarasib does have non-covalent interactions with other
proteins, such as RBM39, that affect drug response and environmental resistance. This work aims
to identify and validate non-covalent interacting proteins of mKRAS inhibitors. In Aim 1, we will
utilize two different mass spectrometry-based proteomics techniques for making large-scale
measurements of protein folding stability to identify non-covalently interacting protein targets of
four KRAS inhibitors, Sotorasib, Divarasib, MRTX1133, and RMC-6236 using cancer cells bearing
the targeted mKRAS. The shared and compound-specific non-covalent candidate interacting
proteins of these inhibitors will be further prioritized and validated to confirm the direct interaction
of these inhibitors with their newly identified protein targets using conventional protein-ligand
binding assays. In Aim 2, we will determine the effects of these inhibitors on the levels and
activities of these non-KRAS interactors. Furthermore, we will elucidate the functional effects of
these interacting proteins by their influence on sensitivity and KRAS pathway activities with or
without environmental resistance. The completion of the proposed study will elucidate the role of
non-covalent and non-mKRAS interacting proteins of mKRAS inhibitors that may explain the
response heterogeneity, mitigate resistance, and enhance response to mKRAS inhibitors.

Public health relevance
Narrative Our research aims to discover how certain cancer drugs, called KRAS inhibitors, work beyond their primary target. KRAS mutations drive many aggressive cancers, and for years, they were considered untreatable until these new drugs were developed. By identifying other proteins that interact with these drugs, we hope to understand why some patients respond better than others and develop new treatments to overcome drug resistance and improve cancer outcomes